Behavioral and Neural Substrates of Odor-Guided Navigation in the Human Brain

ABSTRACT
Sensory systems have evolved to help meet the behavioral needs of organisms to ensure survival. Across the
animal kingdom, two sensory functions are paramount: first, to identify specific objects in the environment and
endow them with salience; and second, to move closer to objects of desire and away from objects that are best
avoided. These properties – identification and localization – are the “what” and “where” questions of sensory
information processing, respectively, and each of the senses provides a unique snapshot of the world that
complements the other senses. In the unique case of olfaction, orthonasal and retronasal olfactory channels
ensure that odor sources can be identified and tracked with fidelity at distal, proximate, and intraoral distances.
This proposed project will focus on the “where” question of information processing in the human olfactory
system. In particular, we aim to understand the capacities, constraints, and mechanisms by which odor cues
orient and steer a navigator in the right direction. In this regard, a singular aspect of odors is their ability to
travel through the air over long distances, such that the olfactory system can gather valuable predictive
information not only about the physical location of an odorous source, but also about the navigator’s position
within a physical landscape. Critically, while elegant neurobiological studies on odor navigation have been
conducted in insects and birds, basic research on this topic in mammals, including humans, is sparse.
Our planned studies are inspired by groundbreaking experiments showing that different types of neurons can
encode and map physical spaces, including “place cells” (representing specific locations in space) and “grid
cells” (representing an internal coordinate system to self-orient in this space). Here we will use functional
magnetic resonance imaging (fMRI), virtual reality (VR) techniques, and computational methods to determine
whether we can infer the presence of “grid-like” fMRI responses when human subjects navigate through an
odor-rich two-dimensional landscape. In Aim 1, subjects will be asked to navigate a VR arena in which the only
informative sensory cues are olfactory, enabling us to test whether subjects can learn the spatial relational
positions among a set of odors, and whether grid-like responses arise during odor navigation. Aim 2 will test
the stability of olfactory grid-like responses by assessing whether contextual changes in the VR arena induce
remapping of olfactory cognitive maps. Aim 3 will test the behavioral limits of human olfactory navigation by
progressively peeling away all remaining visual cues in the arena. Together these studies should bring
fundamental understanding to the capacities and constraints of human olfactory navigation, and should
highlight neural mechanisms underlying the “where” question of human olfaction, and more broadly, how the
olfactory system tracks and locates odor sources in odiferous environments.

Public health relevance
NARRATIVE By combining cutting-edge human imaging techniques with olfactory psychophysics approaches, “virtual reality” methods, and model-based analyses in healthy human subjects, the proposed research will generate new insights into the behavioral and neural substrates of odor navigation in the human brain. By addressing the “where” question of the human sense of smell, our work will uniquely extend the limited available data on how humans can use their noses to orient and path-find within an odorous landscape. Finally, insofar as deficits in the sense of smell often emerge as an early sign in Alzheimer’s disease, and which is often accompanied by visuospatial impairments and deficits of real-world navigation, the research findings obtained here may yield novel olfactory-based mechanistic frameworks for reorienting patients to their environment.